STRUCTURE AND FUNCTION OF PLASMA LIPOPROTEINS AND APOLIPOPROTEINS

Apolipoproteins A-I, A-II, C-II, A-IV, and E have been isolated from control subjects and patients with a variety of dylipoproteinemias including patients with markedly elevated or reduced plasma levels of cholesterol or triglycerides. The apolipoproteins from control and dyslipoproteinemic patients are used for physical characterization and structural analysis. In addition kinetic studies are performed with apolipoproteins from control as well as dyslipoproteinemic patients to determine the apolipoprotein metabolism in normal volunteers as well as dyslipoproteinemic subjects. Several recent kinetic studies have revealed new insights into the metabolism of lipoproteins in unique clinical syndromes including apoA-I Iowa, apoE Philadelphia, and cholesterol ester transfer protein deficiency. HDL contains several different lipoprotein particles with different physiological functions. The two major particles within HDL are LpA-I and LpA-I:A-II. Several lines of evidence indicate that LpA-I may be more protective against the development of premature cardiovascular disease than LpA-I:A-II. Of particular interest in the nascent form of the LpA-I particle designated pre~ HDL which appears to be particularly effective in the removal of cholesterol from cells. Methods to separate these particles have been applied to the analysis of HDL in normal subjects and patients with low levels of HDL and premature heart disease. A major focus of the research program of the Branch is the development of a transgenic mouse and rabbit program which will provide an opportunity to determine the role of several candidate genes and metabolic pathways including reverse cholesterol transport that may play an important role in the development of premature atherosclerosis. We have develop the FPLC methodology to isolate apoA-I and apoA-II and to determine the lipoprotein profile of control animals and animals with specific gene defects which result in hyperlipidemia.